Revolutionizing Protein Structure Determination with Advanced SWAXS Analysis

Abstract
The overall vision of our research program is to develop new methods and algorithms for probing the structure
and dynamics of biological macromolecules to provide new insights that solve problems in human health. Our
lab develops a combination of experimental tools and novel computational algorithms to maximize the
efficiency and synergy of theory and experiment. One of the experimental tools we use is small and wide-angle
X-ray scattering (SWAXS), which offers valuable insights into protein structures and dynamics in solution at
room temperature. However, current methods for analyzing and interpreting SWAXS data have limitations. We
propose the development of innovative tools to address these challenges. The goals of our research program
over the next five years are to develop the following program areas. We will significantly improve the resolution
of density reconstruction directly from SWAXS data by incorporating information about known protein
structures. We will develop a new tool for modeling SWAXS data by incorporating the most recent advances in
AI-based structure prediction. We will develop new algorithms for improving the accuracy and efficiency of
SWAXS calculations from atomic models, as well as novel validation tools for objectively assessing the quality
of models. We will also develop algorithms and tools for taking advantage of the high brightness and temporal
resolution of X-ray free electron lasers. These advancements will lead to higher-resolution density maps, more
accurate models, and robust methods for model validation. In the long term we will broaden the scope of these
developments, including targeting protein dynamics, membrane proteins in detergent micelles and other
membrane mimetic systems, RNA/DNA/complexes, and novel sample delivery modalities. Overall, our
research program is developing a comprehensive approach that has the potential to revolutionize protein
structure determination using SWAXS and transform the field of structural biology. This will yield new insights
into biomedically relevant systems and improve models for drug discovery and design, enabling more rapid
and effective treatments for many diseases.

Public health relevance
Narrative Our research program is focused on revolutionizing the field of structural biology by developing innovative tools and algorithms to overcome the current limitations in probing the structure and dynamics of biomacromolecules. We aim to enhance the resolution of density reconstruction and modeling, improve the accuracy and efficiency of small and wide-angle X-ray scattering (SWAXS) experiments and calculations, and to develop robust methods for model validation, all of which will lead to more accurate protein models. The potential impact on human health is significant, as these advancements will provide new insights into biomedically relevant systems, improve models for drug discovery and design, and ultimately enable more rapid and effective treatments for a variety of diseases.